The role of the cohesin complex in hematopoietic transformation and leukemia maintenance

PROJECT SUMMARY
In this proposal, we will define the effects of epigenetic dysregulation via Stag2 loss on three-dimensional
chromatin structure and transcriptional regulation. We will define key lineage-specific chromatin features and
validate their hierarchy in differentiation in contrast to stem cell self-renewal. In Aim 1, we will perform low-input
Hi-ChIP assay on Ctcf (loop/TAD-boundary), Rad21 (pan-cohesin loop), ChIP assay for H3K27Ac (enhancer)
and RNA-seq (gene expression) on phenotypically defined mouse and human stem and progenitors to define
population-specific looping events. Using our novel ‘on-off-on’ dual recombinase (Stag2GL) allele, we will first
determine if the restoration of Stag2 can reverse the effects on self-renewal/differentiation and define chromatin
loops 1) perturbed during Stag2 loss and 2) restored after Stag2 reversion. Locus-specific functional assays will
determine the key events required for self-renewal through in vitro studies to phenocopy in ‘Stag2-on' or prevent
reversion in ‘Stag2-off’. In Aim 2, using our low cell input Hi-C and Hi-ChIP techniques to assess chromatin loops
alterations identified in our fully penetrant Stag2/Npm1c and Stag2/Flt3 co-mutant AML models in combination
with the Stag2GL allele. Using a multi-omics approach, we will define the chromatin landscape of Flt3 and Npm1
with and without the antecedent Stag2 mutation. We have created a well-annotated MDS and AML patient
biorepository, as well as a biorepository of healthy bone marrow from hip arthroplasty patients. Using these
primary patient samples, we will map chromatin loops and transcriptional output in stem and progenitor
populations and intersect lineage-specific interactions in human and mouse. Functional validation of chromatin
loops lost or gained in the co-mutant models will be assessed in vitro, prioritizing loci identified in primary AML
patient samples. These models will constitute the system to assess the effects of Stag2 loss on therapeutic
response to standard chemotherapeutic regimens ad well as to emerging targeted therapies such as Menin
inhibition in Npm1c-mutant AML (DSP5536) and FLT3 inhibition in FLT3-ITD mutant AML (gilteritinib). Finally,
Stag2 reversion in this system will definitively determine whether Stag2 is required for the maintenance of AML,
hereby representing a genetic dependency in Stag2-mutant AML. Taken together, the results of this proposal
will elucidate the molecular pathology of Stag2, thus leading to a deeper understanding of chromatin-related
transcriptional regulation, epigenetic plasticity, and the contributions of Stag2 to MDS and resultant secondary
AML and the identification of key novel therapeutic targets.

Public health relevance
PROJECT NARRATIVE Genetic defects in the cohesin complex member Stag2 are recurrently mutated in various human cancers and lead to disruption of tissue-specific gene expression through DNA looping. Using cutting-edge epigenomic techniques, primary patient samples, and a reversible in vivo Stag2 mouse, we will map Stag2-specific chromatin looping in hematopoietic stem and progenitor cells and functionally assess their contribution to the lineage fate and self-renewal. Using these techniques in combination with sequential mutagenesis of the AML driver mutations NPM1c and FLT3ITD, we will determine the effects of altered chromatin structure on leukemogenesis, the effects on therapeutic response, and the requirement of Stag2 for leukemia maintenance.